Neuroimaging Informatics Tools and Resources Collaboratory: Outreach, Infrastructure and Maintenance

Abstract
The NeuroImaging Tools and Resources Collaboratory (NITRC) is an established and award-winning (2009
Excellence.gov award and 2015 HHS Innovates award) repository of information and support for resources
relevant to a broad set of neuroimaging domains and their communities of developers and users. Resources
hosted on NITRC Resources (NITRC-R) include software, hardware, and test datasets; data sets are hosted
publicly in NITRC Image Repository (NITRC-IR), and cloud-based virtual computational processing is provided
by NITRC Computational Environment (NITRC-CE). The purpose of NITRC is to provide neuroscience
researchers with a complete solution to the problem of finding, developing, and sharing neuroimaging and
neuroinformatics software tools, finding and sharing large-scale imaging datasets, and manipulating the
software and the data in high-performance computing environments. NITRC will continue to be a framework
where researchers can identify software and data and seamlessly deliver them to local or cloud-based
computational resources for processing. This will be accomplished through the execution of aims designed to
provide: 1) Content and user maintenance for the established NITRC-R, IR and CE environments; 2)
infrastructure maintenance for the complete development and deployment environments; 3) content expansion
in the existing domains, and identification of new areas that are amenable to NITRC support; and 4) outreach,
user documentation, training, and support for the established NITRC user base. This continued effort will
greatly enhance the delivery of high-performance computing to the large-scale datasets that are becoming the
mainstay of neuroscience research and promote more reproducible publication practices through enhanced
resource sharing.

Public health relevance
Project Narrative The purpose of the NeuroImaging Tools and Resources Collaboratory (NITRC) is to provide neuroscience researchers with a complete solution to the problem of finding, developing, and sharing neuroimaging and neuroinformatics resources. NITRC will continue to be a place where researchers can identify software and data and seamlessly use them for image analysis. This will greatly enhance transparent and more reproducible research practices for the community.